Social determinants of cardiovascular disease risk over the life course

PROJECT SUMMARY
Over the last several decades, cardiovascular disease (CVD) incidence and the prevalence of CVD risk factors
have steadily increased in the Central American region. The rise of CVD in the region has occurred in tandem
with widening social inequities that hamper progress toward health equity, and pose a growing, untenable
burden for its limited public health and health care systems. Training and mentoring the local workforce in
identifying relevant research questions, in the use of appropriate research methods, and in the dissemination
of results to the scientific community, the public, and policy makers is critical to identify and develop
interventions to prevent CVD in the region. Importantly, including diverse perspectives of the very populations
with greatest health needs, through increasing the diversity of the research workforce and Central American
institutions represented, increases the probability that the health needs of all populations are addressed and
inequities are reduced. To this end, researchers from Drexel University and the Institute for Nutrition of Central
America and Panama (INCAP) have established a D43 training program focused on developing the research
capabilities of trainees and local capacity building in the conduct of policy-relevant research on the influence of
social determinants and place-based factors on CVD risk across the lifespan. The proposed administrative
supplement will extend the existing parent training program to include two partner institutions that work
populations that have been underrepresented in research. Training activities for the supplement leverage the
training infrastructure created by the parent training program and will include support for a postdoctoral fellow
and three junior scholars, and methods-oriented workshops to increase analytical capacity of trainees. These
activities will ultimately strengthen the institutional research capacity of new training partners, and,
synergistically research capacity at INCAP by increasing its potential to engage in robust south-south
collaborations. That is, by helping to solidify the foundation for increased south-south collaboration between
INCAP and two partner institutions from Central America, the training goals of this administrative supplement
will help INCAP strengthen its research on in CVD prevention among underserved indigenous and rural
populations. Thus, the training program will contribute to developing a strong and sustainable research
capacity that addresses health inequities and meets the health needs of all populations within Central America
through increasing the diversity of the research workforce.

Public health relevance
PROJECT NARRATIVE Cardiovascular disease prevention and health equity improvement in Central America requires understanding how social determinants and place-based factors influence CVD risk across the lifespan. It is critical to train and mentor a diverse local workforce in identifying research questions relevant to CVD prevention, in the use of appropriate research methods to answer them, and in the dissemination of results to the scientific community, the public, and policy makers. This administrative supplement will increase diversity of the trainees and institutions reached by the parent D43 program, to include trainees and institutions that have not been adequately represented in research.